Increasing the uptake of medication-assisted treatment for opioid use disorder

PROJECT SUMMARY
The goal of this K23 Mentored Patient-Oriented Research Career Development Award is to support the
applicant in developing the critical skills necessary to become an expert in implementing evidence-based
treatments for substance abuse disorders in community settings. This K23 application proposes research to
address Objective 3.4 of the NIDA Strategic Plan: Develop and test strategies for effectively and sustainably
implementing evidence-based treatments, specifically identifying factors that influence effective and
sustainable dissemination and implementation of evidence-based practices for treatment of substance use
disorders and improving access to effective addiction interventions. The mentorship team comprises an
academic-public partnership that combines clinical, academic, and public system expertise in Kyle Kampman,
MD, Geoff Neimark, MD, and a team of advisors. The specific trainings goals are to 1) Gain an in-depth
knowledge of the organization, financing, and delivery of community substance abuse treatment for opioid use
disorder, specifically as it relates to medication-assisted treatment, 2) Use theory-based approaches to identify
specific organizational, practitioner and policy-level factors that could be leveraged to increase implementation
of MAT in community settings; and 3) Develop expertise in designs and methods for conducting randomized
trials of organizational strategies to increase the use of MAT in community settings, which will include: a)
theory-based hybrid multi-level effectiveness-implementation research designs and b) analysis of
administrative (claims-based) data to measure relevant outcomes. The research proposed in this K23 will
focus on agencies that have not previously adopted MAT. Prior research and our pilot data suggest two
categories of MAT non-adopters: those whose barriers are primarily ideological/attitudinal and those whose
barriers are largely practical/logistical. The goal of the proposed study is to investigate both categories of
barriers among community providers, and to develop a resource package to support future initiatives to
enhance MAT capacity. Specifically, the applicant proposes to: 1) Determine what organizational factors and
characteristics of executive directors are associated with a substance use disorder treatment organization’s (n
= 117) decision to adopt in response to a policy incentivizing MAT adoption, 2) Evaluate the implementation
success of the subset of agencies who adopt MAT in response to the initiative, identifying malleable
organizational and psychological factors that lead to successful implementation and 3) Develop a resource
package of MAT adoption and implementation strategies using established tools and identifying new areas for
future research and exploration. Over the course of this project the applicant will develop critical knowledge
and skills in community addiction treatment, implementation science, and public policy, with the expertise of an
experienced and established team of mentors.

Public health relevance
PROJECT NARRATIVE This application proposes to enhance the provision of medication-assisted treatment (MAT) for opioid use disorder in the public sector. The mentorship, training, and research activities will improve the applicant's understanding of factors that influence effective uptake and implementation of MAT in the community, and will inform future research on implementation efforts. The present study has the potential to impact public health by encouraging more rapid and effective implementation of evidence-based treatments, and improve the quality of community-based treatment of substance use disorders.